Drinking water contaminants and fetal loss in Northern California

PROJECT SUMMARY/ABSTRACT
The objective of this R03 proposal is to characterize the rates of miscarriage and stillbirth by gestational week
in a Northern California population, and to evaluate whether climate change-sensitive drinking water
contaminants increase rates of miscarriage and stillbirth. We also aim to estimate the effects of a hypothetical
intervention of reducing water contaminant levels on risk of fetal loss. The relationships between drinking water
contaminants and risks of miscarriage and stillbirth have not been investigated in California since the early
1980s. As climate change threatens the quality of drinking water in the state, it is important to better
understand how climate-sensitive drinking water contaminants affect reproductive health.
There is a significant gap in research on environmental determinants of fetal loss at a population level. This is
likely due to the challenges in studying early fetal loss, as existing data sources have difficulty capturing
miscarriage. However, electronic health record data can help us improve our knowledge of fetal loss between
10 and 20 weeks of gestation, when many pregnant people have received a prenatal care visit but whose
pregnancies would not be captured in birth records.
We propose to use Sutter Health’s electronic medical records to identify pregnancies, and link participants to
community water system boundaries using residential address at each clinic visit. We will then assign water
contaminant levels based on the annual average contaminant levels collected from public water monitoring
information at the water system level in California. The goals of this project are to 1) characterize the rate of
fetal loss in a diverse California cohort, 2) evaluate the individual and mixture effects of climate-sensitive water
contaminants on rates of fetal loss, and 3) assess whether reducing all water contaminants to their 50th
percentiles observed in the study cohort reduces the risk of fetal loss.
The research plan is supported by a strong team of investigators from UCSF, Sutter Health, UC Berkeley, and
Columbia University. The investigators have a strong history of collaboration and experience working with
electronic health records. They bring significant expertise in reproductive health, drinking water contaminants,
climate change, and environmental justice.
This research addresses a significant gap in the literature and aligns with both NIEHS’s goal to generate
evidence that can be used by policymakers to improve population health, and NICHD’s goals to understand
contributors to pregnancy loss and to help identify targets for effective prevention of health disparities.

Public health relevance
PROJECT NARRATIVE Climate change is projected to affect drinking water quality in California, exacerbating existing environmental justice concerns around contaminant levels in community water supplies. This project will evaluate the relationship between fetal loss and climate-sensitive drinking water contaminants, helping to ensure regulation of drinking water quality in California protects maternal and fetal health.